Does neurotransmitter plasticity of para-serotonergic neurons augment autoresuscitation following perinatal stress and buffer SIDS risk?

Project Summary: A robust autoresuscitatory reflex (AR) is critical to newborn survival from birth. The
transition to independent breathing and accommodation of breathing interruptions, apneas, that are common in
neonates and infants, requires a coordinated cardiorespiratory response for recovery. 5-hydroxytryptamine (5-
HT, serotonin) and the brainstem raphe cells that produce it, referred to as Pet1 neurons, organize and drive
successful AR in newborn animals and humans. Unsuccessful AR is understood to be a major contributor to
the sudden infant death syndrome (SIDS), where alterations in the brain 5-HTergic system have been
described in ~half of human SIDS cases, including increased number of 5-HT neurons of differing morphology
(smaller, simpler, perhaps immature), deficiencies in autoreceptor 5-HT1A binding, and decreased levels of 5-
HT and tryptophan hydroxylase 2 (TPH2, the rate-limiting biosynthetic enzyme for 5-HT). We propose
investigations to reveal in mice how aspects of this SIDS brain 5-HTergic phenotype develop prenatally. Our
approach is informed by two recent findings. First, Pet1+ neurons in the raphe expressing high levels of 5-HT
identity genes (e.g. Ddc, Vmat2, Gata3, Pet1) have been identified, smaller in size, with modest levels of
autoreceptor 5-HT1A yet remarkably expressing little or no TPH2 and 5-HT. We call these novel cells para-5-
HTergic neurons, signifying their partially shared molecular phenotype, shared location, and developmental
emergence with 5-HT neurons. Second is the discovery of neurotransmitter switching, a noncanonical form of
neuronal plasticity that occurs in response to stressors. Recent data support its role in shaping the 5-HTergic
neuronal system, where stressors may drive some para-5-HT neurons to produce 5-HT as an adaptive
response. Preliminary findings reveal that para-5-HT neurons derived from rhombomere (r) 4 densely and
selectively innervate respiratory and arousal centers, and that gestational exposure to intermittent hypoxia
results in an increased number of TPH2+ cells postnatally with as yet uncertain 5-HT levels. We propose that
para-5-HT neurons are a pliant population that may be transformed when challenged prenatally by
hypoxia to produce 5-HT in newborns as a compensatory mechanism to support AR. We hypothesize
that in response to the major SIDS risk factor of prenatal hypoxia, certain para-5-HT neurons adaptively
transform to produce 5-HT to rectify a 5-HTergic signaling imbalance that hinders the AR and,
alternatively, that an insufficient transformation plays a critical role in SIDS. We will test this by exposing
mice to intermittent hypoxia or normoxia during gestation, characterizing cellular and molecular phenotypes
and querying neurotransmitter transformation (Aim 1); further, we will determine the effect of acute activation
or inhibition of these r4-para-5-HT neurons on the AR in these mice (Aim 2), and we will examine phenotypic
markers of para-5-HT neurons in human SIDS and control brain tissue (Aim 3). This novel, functionally
defined, para-5-HT cell type and plasticity may be highly relevant to newborn viability.

Public health relevance
Narrative Neonates and infants frequently experience breathing interruptions, called apneas, and an impaired response to these apneas may begin a process that tragically ends in Sudden Infant Death Syndrome (SIDS). Autoresuscitation is the reflex process that allows babies to recover successfully from apneas, and serotonin, a neurotransmitter in the brain, plays an essential role organizing and driving this reflex, yet it seems likely that many babies who died of SIDS lacked sufficient serotonergic neuron function in the brainstem, which may be the reason that autoresuscitation fails in these babies. We have discovered a set of neurons, we call `para- serotonergic neurons,' that may transform into serotonin-producing cells as part of a compensatory neural adaptation to stress that promotes a normal autoresuscitation response and reduces the chance of SIDS, and we propose deep functional and molecular characterization of these cells, motivated by their potential as a therapeutic target for pediatric disorders involving cardiorespiratory dysfunction.